Project Milestones: Young Adult Cancer Survivorship

ABSTRACT
Over 70,000 adolescents and young adults (AYAs; age 15-39 years) are diagnosed with cancer every year in
the United States, more than 8 times the number of younger patients. Survivors of AYA cancer are unique due
to their life stage and lack of appropriate services for this population (e.g., fertility preservation, insurance
coverage, and educational/vocational support). In contrast to young adult survivors of childhood cancer, little
systematic research has been conducted among survivors of AYA cancer to understand their health-related
outcomes. At diagnosis and during treatment, AYAs face delayed and limited access to appropriate care,
lower clinical trial enrollment, greater treatment-related toxicity and morbidity, and inferior survival. Early post-
treatment studies of AYA cancer survivors indicate numerous financial, social, and personal burdens
associated with cancer diagnosis and treatment. However, the long-term cancer survivorship experience
among survivors of AYA cancer is largely unexplored. Cancer during young adulthood likely leads to loss or
delay in achieving milestones of adulthood (e.g., full-time employment, financial health, marriage, having
children) following cancer treatment. Additionally, young adult Hispanic cancer survivors are understudied,
despite evidence that Hispanics experience significant differences in health-related outcomes.
Project Milestones will address these research gaps by recruiting and surveying a population-based cohort
(n=2,000, ~42% Hispanic) representing long-term (3-10 years post-diagnosis) survivors of the most prevalent
cancers found in older AYAs diagnosed between ages 21-39. Our specific aims are: (1) To assess risk and
protective factors of the achievement of milestones of adulthood and to compare achievement of milestones
between survivors of AYA cancer and non-cancer comparators; (2) To assess risk and protective factors of
long-term well-being and health related quality of life (HRQOL); and, (3) To assess risk and protective factors
of engagement in cancer-related follow-up care. For all outcomes, we will examine age, cancer type, and
ethnic differences. Among Hispanic survivors, we will examine cultural factors associated with study
outcomes.
This population-based study will include prototypical AYA cancer cases ascertained through the Los Angeles
County Cancer Surveillance Program Cancer Registry. Self-report surveys will assess milestones of
adulthood, well-being, HRQOL, and cancer-related follow-up care. Multivariable regression analyses will
identify protective and risk factors for milestones, HRQOL and cancer-related follow-up care. Comparative
analyses will identify differences between Hispanic and non-Hispanic AYA survivors and between AYA cases
and non-cancer comparator participants (from the California Health Interview Survey). Results will inform the
development of guidelines and programs supporting survivors of AYA cancer, including addressing and
reducing health disparities affecting those of Hispanic ethnicity.

Public health relevance
PROJECT NARRATIVE Roughly 70,000 adolescents and young adults (AYAs; between the ages of 15-39) are diagnosed with cancer every year, an incidence that is nearly 8 times greater than in childhood cancers. Preliminary research indicates that young cancer survivors suffer from considerable challenges due to their life stage. The goal of this study is to develop a population-based cohort (n=2,000) of young adult survivors (ages 21-39; ~42% Hispanic) of the most common types of cancers in this age group who are 3-10 years post-diagnosis. We will examine their health status, including comorbidities and late effects of their cancer treatments, achievement of adult milestones, and use of health care services. Findings will provide physicians and other health care providers with evidence to guide policies concerning young adult cancer survivorship care.